Understanding and controlling antibiotic resistance

Project IV: Understanding and Controlling Antibiotic Resistance studies drug resistance in gonorrhea, tuberculosis, and pneumococcal infections, applying methods from earlier projects to understand the genetic and selective origins of resistance and the mechanisms underlying observed heterogeneities in its prevalence.